The Live Long Walk Strong rehabilitation program: What features improve mobility skills?

Slow walking speed is highly prevalent among Veterans beginning in midlife. It is a major predictor of
functional independence, independent of disease status and a predictor for subsequent hospitalization,
disability and death. While rehabilitative care is the standard treatment for those with slow gait speed, the
optimal mode of treatment is not yet identified. We have strong clinical support that a new model of physical
therapy care known as Live Long Walk Strong (LLWS) may be an efficacious treatment for those screened
with slow gait speed. LLWS is highly innovative, as it prioritizes unconventional treatment targets not typically
addressed in standard care, including impairments in: 1) leg power; 2) trunk muscle endurance; 3) gait
coordination (smoothness of walking); and 4) self-efficacy to engage in exercise. Through prior research, we
identified that each of these four therapeutic targets are linked to mobility decline when impaired and that
improvements in each alone can lead to mobility gains that surpasses standard care. No treatment targeting
these attributes collectively is established, though LLWS is conceptually designed to do so. [Thus, we propose
a phase II randomized controlled clinical trial (RCT) among Veterans 50 years and older to identify if LLWS
care enhances these attributes and if by augmenting each, sustained improvements in gait speed result.]
In a civilian-based clinical demonstration project, clinical proof of concept of LLWS was observed.
LLWS targeted community-dwelling older adults. At the completion of LLWS care, we observed large
improvements in mobility performance that exceeded clinically meaningful differences. These differences were
observed even after accounting for health factors that may mitigate rehabilitative gains. [LLWS has great
significance for the VA, because slow gait speed is prevalent in middle aged Veterans and improvements of
the magnitude we observed are predictive lower health care costs and disability. However, while LLWS was
clinically conceived to improve gait speed by enhancing each of these attributes, it is critical to know if two
basic suppositions are true: 1) Are each of these four attributes improved by LLWS? and 2) Do these
improvements induce immediate and sustained changes in gait speed among veterans beginning in midlife?
Therefore, this study will establish efficacy and proof of concept of LLWS among Veterans beginning in midlife;
an age-range largely ignored in prior clinical trials targeting gait speed.]
LLWS has tremendous relevance for the VA. [For example, in our preliminary work among 174 Veteran
primary care patients aged 50-98, >50% manifested a gait speed < 1.0 m/s, a speed indicating a heightened
risk for adverse health outcomes.] Given Veteran’s higher levels of impairment compared to aged matched
civilians, care should be as parsimonious and efficacious as possible. Thus, the major goal of this proposal is
to establish LLWS as a non-invasive, new therapy targeting slow gait speed across a variety of VHA settings.
In the proposed phase II RCT, we will recruit [198 community-dwelling, Veterans 50 years and older]
from the outpatient clinics of the VA Boston Healthcare system that manifest slow gait speed (< 1.0 m/s) and
randomize them to either 8 weeks of LLWS or 8 weeks of usual care for those with slow gait speed after which
LLWS will be initiated for 8 weeks. Both groups will be followed for outcomes 16 weeks after LLWS treatment
ends. [The primary outcome for all 3 aims will be change in usual gait speed. Secondary outcomes will include
changes in the targeted attributes after 8 weeks of treatment.]
We will address these aims:
[Aim 1: To conduct a phase II RCT of LLWS in comparison to controls and evaluate its efficacy among
community dwelling Veterans 50 years and older.
Aim 2: Evaluate the attributes that lead to improved gait speed after 8 weeks of LLWS treatment.
Aim 3: Identify the attributes that are associated with sustained gait speed gains 16 weeks after LLWS ends.]

Public health relevance
This study addresses middle-aged and older adult veterans with slow gait speed. Slow walking speed is a frequent patient complaint and is associated with bad health outcomes including disability and death. Physical therapy (PT) care is the usual treatment for older adults with slow gait speed, but the optimal model of PT care is not known. Outside of the VA, we developed Live Long Walk Strong (LLWS) which is a program of PT care that builds upon our research identifying new treatments with greater benefit than usual care. We must confirm that LLWS can benefit Veterans beginning in midlife. We intend to conduct a study of LLLWS among community dwelling Veterans in comparison to usual care. We will evaluate the benefits that LLWS provides on walking skills and the qualities that lead to walking skill improvements. We will also evaluate if the benefits of LLWS last up to 16 weeks after treatment ends. If successful, this study will establish LLWS as a treatment targeting health and functional independence, which can be provided in a variety of VA care settings.